Determinants of Idiopathic Inflammatory Myopathy Associated Interstitial Lung Disease.

COVID-19 Related Disruption Summary Dr. Johnson is a current Mentored Career Development Grant recipient, K01HL1359, in the final year of her award. This disruption statement outlines the specific COVID-19 pandemic-related interruptions to the conduct of Dr. Johnson's research program over the past fifteen months. Dr. Johnson experienced a 12-week clinical research interruption because of COVID-19. The University of Pennsylvania School of Medicine suspended all clinical research without a potential direct impact on patient quantity of life (all observational clinical studies) in March 2020. Non- essential research operations began in phases at limited capacity after Office of Research Services approval in June 2020 ? Dr. Johnson's resumed on-campus research operations in September 2020. The university suspended all hiring in March 2020. The University of Pennsylvania Interstitial Lung Disease (ILD) Program provides part-time clinical research coordinator support to Dr. Johnson. The ILD program was hiring a new research coordinator prior to the start of the COVID-19 pandemic. The interview and hiring process was suspended per the university's guidelines, leaving Dr. Johnson without clinical research coordinator support for five months. Dr. Johnson experienced a 50% increase in clinical duties because of COVID-19. This involved more clinical service time commitments, including unscheduled service time in the novel COVID and traditional non-COVID intensive care units. Further, Dr. Johnson was on emergency jeopardy coverage (on call at all times) for four months between March 2020 and July 2020. Dr. Johnson was also subjected to increased childcare responsibilities. In March 2020 the daycare centers for both of her children (ages 4 and 1) temporarily closed. Dr. Johnson did not hire a caretaker to come into the home because of concerns about COVID-19 exposure. Dr. Johnson's older child now attends public school in the city of Philadelphia. The Philadelphia School district used a fully virtual (child learns at home remotely via synchronized online classes) model until April 2021. In April 2021 the school district started a hybrid learning model (child attends school in-person twice weekly with virtual learning the remaining three days a week) which continued through the conclusion of the 2020-2021 school year. Dr. Johnson provided 95% of the in-home learning support for her older child throughout the school year. In summary, the COVID-19 pandemic due to increased clinical service time, university and health- system-wide hiring freezes, restrictions on the conduct of research, and increased childcare responsibilities negatively affected Dr. Johnson's research productivity.

Public health relevance
Project Narrative Idiopathic inflammatory myopathy associated interstitial lung disease (IIM-ILD) is a significant cause of excess morbidity and mortality in patients with IIM. Accurate quantifiable measures that predict IIM-ILD development do not exist. This research will lead to a better understanding of why some patients with IIM develop ILD while others remain free of ILD.